Attracting Talented Students to Biomedical Informatics and Data Science Careers Through Short-Term Study at OHSU

The main goal of the Oregon Health & Science University Biomedical Informatics and
Data Science College Undergraduate Summer Internship Program is to provide a rich,
full-time experience to students to graduate study and careers in biomedical informatics
and data science. In addition, the program aims to motivate students to pursue doctoral
training in biomedical informatics and data science that leads to research careers in
academia, government, healthcare, and industry. With assistance and coordination from
Portland State University, we will support nine students per summer in an experience
that includes: · Knowledge of the motivations, activities, and challenges for the
biomedical informatics and data science field · Skills development in data science
through the use of data sets and standard tools · Participation in a faculty-led research
project · A student-led and faculty-facilitated health data ethics seminar · Scientific,
career, and near-peer mentoring.

Public health relevance
The main goal of the Oregon Health & Science University Biomedical Informatics and Data Science College Undergraduate Summer Internship Program is to provide a rich, full-time experience to undergraduate students to graduate study and careers in biomedical informatics and data science. With assistance and coordination from Portland State University, we will support nine students per summer in an experience that includes knowledge and skills development, participation in a research project, a health data ethics seminar, and scientific and career mentoring.